Research Practice Partnership: Supporting Nevada's Cancer Coalitions Priorities

PROJECT SUMMARY The proposed project addresses a Nevada State Cancer Plan and Nevada Cancer Coalition (NCC) priority area of tobacco—a priority area shared by multiple stakeholders across the state and who are included in the project—while also affording NCC opportunities to grow its work disseminating evidence-based interventions (EBI) and supporting healthcare systems in the implementation of EBIs. We now have state-wide funded projects in Utah to address tobacco cessation (PCORI), colorectal cancer screening (CDC), HPV vaccination (ACS), opioid use (NIH), and COVID-19 (NIH) with a similar set of partners (e.g., cancer coalition, state department of health, primary care association, CHCs). Our vision is that the proposed project will build the foundation for expanding Huntsman Cancer Institute (HCI) and HCI’s Cancer Control and Population Science’s research to Nevada in the same way. The proposed project is built around the EPIS framework and Research Practice Partnership model. It will engage multiple partners and project team members, along with processes and procedures to increase engagement with the Nevada Tobacco Quitline (NTQ) by implementing the EBI Ask-Advise-Connect in Community Health Centers (CHC). Primary care is the largest platform for the delivery of health care and provides an ideal setting to address tobacco cessation because there is an established relationship and coordination of care. Moreover, tobacco use both nationwide and within Nevada has become increasingly concentrated among individuals with low education, living in poverty, and the uninsured and unemployed. For example, in Nevada individuals with an income level of $50,000 or more had a smoking prevalence of 12.6% compared to a 22.2% prevalence among individuals making <$24,999.4 As such, CHCs, which serve patients regardless of their ability to pay, are extraordinary venues for reaching underserved populations with evidence- based treatment for tobacco cessation. The NTQ provides evidence-based treatment for tobacco use, but is grossly underutilized with Nevada ranking among the lowest states in Quitline utilization at 1.4 callers receiving medication/counseling for every 1000 tobacco users.5 The project will include a systematic evaluation that gathers on-going feedback from partners/participants, while also evaluating the effectiveness of the AAC adaptation and implementation using data available from the CHCs, NTQ, and HRSA’s Uniform Data System (UDS).

Public health relevance
PROJECT NARRATIVE The proposed project addresses tobacco cessation efforts in underserved populations and low resource healthcare settings across the State of Nevada with a focus on increasing engagement with the Nevada Tobacco Quitline (NTQ) through the evidence-based intervention (EBI) Ask-Advise-Connect (AAC). Tobacco is a priority are of the Nevada State Cancer Plan and Nevada’s Cancer Coalition (NCC)—a priority area shared by multiple stakeholders across the state and who are included in the project—while also affording NCC opportunities to grow its work disseminating EBIs and supporting healthcare systems in the implementation of EBIs.